Support for Evaluation Activities in the National Cancer Institute

"This contract provides support for evaluation activities conducted by the Office of Physical Sciences in Oncology located within the Center for Strategic Scientific Initiatitves at the National Cancer Institute. "